iPediHeart: Interdisciplinary Research Training Program for Pediatric Heart Disease

Summary/Abstract Section
Congenital heart disease, the most common birth defect affecting 1% of births, remains the leading cause of birth defect-related mortality in the US and worldwide, accounting for nearly 50% of such deaths. Additionally, acquired heart diseases such as pediatric-onset heart failure and cardiomyopathy are increasingly recognized as distinct from adult-onset disease, with limited treatment options and insufficient evidence to guide existing therapies. Adult cardiovascular disease often originates in childhood, with a growing burden of hypertension, diabetes, and obesity among children. Together, these challenges underscore an urgent need to expand the pipeline of highly trained scientists and physician-scientists capable of advancing pediatric and congenital cardiology research. Further, scientific researchers are needed to investigate the genetics, molecule/cellular mechanisms, therapies, and outcomes for children with heart disease across the translational research spectrum. The proposed Interdisciplinary Research Training Program for Pediatric & Congenital Heart Disease (iPediHeart) T32 will address this workforce need by training Scholars in rigorous, multi-disciplinary research, from preclinical science to health services and population-level investigations. iPediHeart will leverage existing institutional partnerships to recruit a highly qualified pool of candidates committed to improving outcomes for children with heart disease. The faculty represent a broad group of investigators, including world-leading experts and promising early-stage faculty, ensuring individualized mentor-mentee pairings and collaborative mentorship structures. iPediHeart will advance three central training aims: (1) build research knowledge through an integrated core curriculum; (2) provide structured training in grant writing and scientific communication; and (3) deliver individualized mentorship, career development, and scholarly oversight. The two-year curriculum features a monthly colloquium for Scholar-led research discussions, an annual symposium highlighting innovative research, and interactive workshops designed to build grant writing skills, culminating in mock study sections simulating the peer-review process. Through this integrated, multi-disciplinary framework, iPediHeart will develop a sustained pipeline of scientists and physician-scientists who secure research-focused faculty positions, obtain independent funding, and advance the scientific foundation needed to improve outcomes for individuals affected by pediatric and congenital heart disease.

Public health relevance
Modified Project Narrative There is an urgent need to expand the pipeline of highly trained scientists and physician-scientists equipped to advance research across the spectrum of pediatric and congenital heart disease. The Interdisciplinary Research Training Program for Pediatric & Congenital Heart Disease (iPediHeart) is designed to meet this need by providing post-doctoral research fellows with rigorous, individualized research mentorship, a custom-tailored curriculum, and direct engagement with multi-disciplinary research mentors. By cultivating the next generation of experts through intensive scientific training and cross-disciplinary collaboration, iPediHeart will strengthen the field and accelerate the discovery of innovative strategies to improve outcomes for individuals with pediatric and congenital heart disease.